Characterize Emerging HIV Strains from Blood Donors and Patients

To characterize and analyze multiple, diverse HIV isolates from different parts of the world for NIAID’s ongoing efforts to develop a well characterized repository for diagnostics, drug and vaccine studies.